BONE TURNOVER AND LOSS IN MEN OVER 75 YEARS

Men over 75 years of age evaluated at one time point for sex hormone levels, bone turnover markers, bone mineral density, calcium regulating hormones. A correlation was found between bone turnover markers and bone mineral density in this group. A decrease in testosterone and increased PTH were also observed. This study has now been completed. Data is currently being analyzed.